Efficacy of a group-based videoconference intervention to increase physical activity in cancer survivors

Project Summary/Abstract
Moderate to vigorous intensity physical activity (MVPA; i.e., aerobic and resistance exercise) improves physical
function and quality of life for cancer survivors, and is associated with reductions in cancer-specific and all-cause
mortality. Unfortunately, recent estimates suggest that only 14% of individuals with a cancer history are engaging
in the amount of MVPA considered necessary to achieve these health benefits. Thus, there is a need for effective
and wide-reaching interventions that can help cancer survivors increase MVPA. Supervised group-based
interventions are successful in increasing MVPA among cancer survivors, however, delivering these
interventions face-to-face can be resource intensive, and present a barrier in terms of access. Virtually
supervised PA interventions (i.e., using videoconferencing) can offer the benefits of real-time supervision and
social interaction, while retaining the scalability and reach advantages of other remote delivery modalities. To
date, there have been no large-scale, randomized controlled trials testing the efficacy of a group-based
videoconference intervention to increase MVPA in cancer survivors. This study will examine the effect of a group-
based videoconference intervention to increase MVPA and improve health outcomes among cancer survivors
and explore behavioral mediators and moderators of intervention effects. We will randomize adult cancer
survivors to the 12-week intervention, or a comparator group. The intervention will include twice-weekly instructor
led group-based aerobic and resistance exercise, and PA behavior change discussion sessions. Outcomes will
be assessed at baseline, 12-weeks (post-intervention) and six-month follow-up. All study visits and intervention
components will be delivered in-real time using videoconferencing software. The primary outcome will be weekly
minutes of MVPA, measured using an accelerometer and a validated self-report questionnaire. Secondary
outcomes are self-reported quality of life, and physical fitness as assessed by the sit-to-stand test and 2-minute
step test. An exploratory outcome of the study will be to examine the effect of the intervention on loneliness.
Videoconference technology has the potential to expand the reach and scalability of supervised, group-based
interventions, thus presenting an effective way to help cancer survivors increase MVPA and connect with other
participants.

Public health relevance
Public Health Impact Supervised, group-based interventions are effective for helping cancer survivors increase physical activity and improve quality of life. Videoconferencing has the potential to vastly expand the reach and scalability of these interventions, while retaining the key components of accountability and social support. Given the positive impact that aerobic and resistance exercise can have on multiple health outcomes and cancer-survival, if many cancer survivors can achieve and sustain recommended levels of physical activity, the public health impact would be substantial.